BioAnalytical Chemistry Core

BIOANALYTICAL CHEMISTRY CORE – PROJECT SUMMARY
In the rapidly changing field of environmental health science, research needs are diverse and complex,
requiring integration of sophisticated bioanalyses including the ability to identify and quantitate trace metal
speciation and xenobiotic interactions with biomolecular targets. Performing these analyses requires highly
trained personnel with specialized expertise and access to advanced high-end equipment, beyond what is
typically available in most individual research laboratories. The BioAnalytical Chemistry Core (BACC)
provides the NM-INSPIRES Center investigators with the necessary expertise and tools for a variety of modern
bioanalyses. Moreover, the Core provides in-house analyses, supports innovative protocol development, and
provides training to students, fellows, and faculty in the integrated applications associated with the advanced
analytical instrumentation present in the facility. The Core additionally leverages access to several other
existing on-campus core facilities to enable innovative biomolecular methods and provides these services at
subsidized pricing. Even more important than access to the technology, the BACC provides tailored expertise
to investigators to assist in the design of molecular analyses and data interpretation to optimize the utilization
of valuable biological samples and resources. The facility will be managed by our Core leaders and
knowledgeable staff scientists with strong complementary expertise in bioanalysis and research facility
administration. The Core equipment is primarily housed in dedicated space in close proximity to most users.
This centralization of resources and knowledge provides consolidated and cost-effective bioanalytical services
and technical expertise to the Center members and users. The Core is organized into four units: Metals
Analytical Chemistry, Oxidative Stress, Environmental Mass Spectrometry, and Advanced Genomics. These
complementary components together will provide Center investigators with a continuum of bioanalytical
capabilities for comprehensively characterizing the response to environmental exposures and contaminants.
The Specific Aims of this Core are 1) to provide consultation in the design, execution and interpretation of
studies that require the use of advanced analytical instrumentation for environmental research; 2) to develop
and validate novel analytical methods for detection and quantitation of environmental species in complex
samples; and 3) to provide education and training in analytical methods for environmental research through
personal outreach, courses and workshops, enabling the integration of cutting-edge analytical technologies
into the research of NM-INSPIRES members. Overall, the BioAnalytical Chemistry Core will add considerable
value to environmental health research at the University of New Mexico by leveraging existing institutional and
NIH investments in research infrastructure to achieve the goals of our NM-INSPIRES research team.